Transcription Factor 4 (TCF4) Regulation of Corneal Health

PROJECT SUMMARY
Fuchs endothelial corneal dystrophy (FECD) is a bilateral, heritable degeneration of the corneal endothelium
that affects roughly 4% of the population older than 40 years in the United States. FECD is one of the most
common indications for corneal transplantation. Major advances in genomics have dramatically increased our
understanding of FECD, and identified diverse genetic and epigenetic causes and associations. In particular,
traditional linkage studies and GWAS studies identified an expanded CTG trinucleotide repeat (TNR)
expansion (named CTG18.1) in the non-coding region of transcription factor 4 (TCF4) gene as the most
strongly associated genetic alteration associated with late-onset FECD. The intronic TNR expansion within the
TCF4 gene is responsible for about 70% of FECD cases in European populations. Despite these substantial
advances made in identifying risk alleles and biological pathways that are involved in the development of
FECD, definitive treatment of FECD has mainly remained surgical with corneal transplantation. Effective
medical treatments for FECD are lacking. A major challenge in the field of FECD research is the absence of a
mouse model of the TCF4 repeat expansion. Mouse models have been developed for other genes associated
with FECD (COL8A2, Slc4a11) but these genes are responsible for only a minority of cases. Thus, current
models for studying TCF4 repeat expansion FECD include ex-vivo specimens, primary cell cultures, and
immortalized cell lines derived from tissue specimens obtained from patients with advanced FECD undergoing
corneal transplantation. An in vivo model of the TCF4 repeat expansion is needed, in particular one that could
be used to study early stage FECD. The main roadblock has been the challenge of creating animal models
with large uninterrupted repeats due to the technical difficulties. In preliminary studies, we have developed a
novel method for generating knock-in mouse models of trinucleotide repeat expansion disorders. Our unique
approach takes advantage of CRISPR and the highly efficient microhomology-mediated end joining (MMEJ) to
knock in trinucleotide repeats into gene loci. This approach has enabled us to knock in 338 CTG repeats into
the Tcf4 locus and successfully generate Tcf4-CTG338 knock-in heterozygous mice. Our overall objective is to
determine how the TCF4 repeat expansion contributes to FECD pathogenesis so that new therapeutics may
be developed. In our Specific Aims, we take two major strategies: characterize mice with a short TCF4 repeat
(338 repeats) that have already been generated and develop mice with a long TCF4 trinucleotide repeat (1,346
repeats) as repeat expansion length is correlated with corneal disease. We hypothesize that mice with a TCF4
repeat expansion can serve as an in vivo model for CTG expansion-mediated FECD. We anticipate that this
project will ultimately establish new insight into how a TCF4 repeat expansion contributes to FECD disease
and uncover promising therapeutic targets. More broadly, this work establishes a platform to develop novel
mouse models for the study of trinucleotide repeat expansion diseases.

Public health relevance
PROJECT NARRATIVE Fuchs endothelial corneal dystrophy (FECD) is a leading indication for corneal transplant surgery. A trinucleotide repeat expansion in the non-coding region of transcription factor 4 (Tcf4) gene is the most strongly associated genetic alteration associated with FECD. This research proposal will develop a novel mouse model with this genetic alteration that may be used as an important research tool to better understand the mechanisms of this eye disease.